A systems-level perspective to addressing health harming legal needs via a joint Health Equity Collective and MLP network approach"

PROJECT SUMMARY
Adverse social determinants of health (SDoH) disproportionately impact low-income and communities
of color. The multisectoral alignment of expertise and resources can effectively target these adverse SDoH
needs through innovation and diverse perspectives; and one such example is that of medical legal
partnerships (MLPs) wherein healthcare institutions work with legal entities to address adverse social needs
through legal remediation. These adverse social needs are thereby referred to as health harming legal needs
(HHLNs) as they depend on legal support for resolution. While there has been great interest in MLP
implementation, research on its efficacy and factors that predict implementation success is lacking in clinical
settings. Furthermore, none of these existing experimental studies were conducted in the southern region of
the U.S, thus omitting geographic and cultural contexts to MLP implementation. Given this limited availability of
research in support of effectiveness, we propose a systems-level approach to explore the impact of a patient-
informed MLP intervention that resolves HHLNs in pediatric families enrolled across UT Physicians
multispecialty clinics. This approach integrates the community voice (patient) perspective to identify lived
experiences (themes) within the clinic setting that may impede the screening and care coordination process.
As such, we will use key informant interviews to qualitatively explore and identify themes that influence
patients' experiences with
on
feedback
screening and resource access for adverse social needs, with particular emphasis
factors that may impact utilization of an MLP program to resolve these needs (Aim 1). We will then leverage
from Aim 1 tobuild an evaluation framework and protocol for assessing the reach, effectiveness,
adoption, implementation, and maintenance of a real world MLP intervention (Aim 2a). This evaluation
framework will be subsequently utilized in our quasi-experimental study to assess MLP effectiveness and
factors that impact implementation in pediatric families who visit UT Physicians multispecialty clinics (Aim 2b).
Successful project completion will inform MLP implementation across clinics, strategies to better target at-risk
populations, and the submission of an R01 application where we can assess the efficacy of an MLP
intervention and further examine MLP expansion and implementation across clinics in the Greater Houston
area.
To date, my my research has examined the impact of demographic, social, and contextual factors on
adverse behavioral and health-related outcomes among low-income and minority groups. The mentorship of
Drs. Sharma, Murphy, Liaw, and Huber supported by this K01 mechanism will ensure that I continue to acquire
knowledge and advanced training in relevant qualitative and quantitative methodologies, systems-level
interventions, and community based participatory research strategies for informing research activities.

Public health relevance
PROJECT NARRATIVE A system-level perspective such as the medical legal partnership (MLP), resolves health harming legal needs (HHLNs) through clinical and legal partnerships and may prove beneficial for improving patient and clinic level health outcomes. This project applies a systems-level perspective via collaborative support from the Houston Health Equity Collective (key informant interviews) and the UTHealth MLP network (patient-informed quasi-experimental study) to address HHLNs in a low-income racially-ethnic diverse sample. Successful project completion will inform researchers, clinicians, and public health experts of how a systems-level prevention perspective care can resolve adverse needs and improve health-related outcomes in at-risk populations.